Protein Labeling and Crosslinking by Covalent Aptamers

PROJECT SUMMARY
The overall goal of this proposal is to develop a fundamentally new class of oligonucleotide agents – covalent
aptamers – that will have a major impact on nucleic acid-based reagents and therapeutics. Covalent aptamers
will be an enabling methodology behind new aptamer applications and will provide new solutions to persistent
limitations of this compound class. Aptamers are engineered oligonucleotides that bind protein targets and have
found applications in a multitude of areas, including therapeutics, diagnostics, drug delivery, and imaging. They
bind their targets with affinity and specificity that rivals those of antibodies, while displaying lower production
cost, higher production consistency, and the ability to easily introduce chemical modifications. Capitalizing on
the ability to amplify and sequence nucleic acids, aptamers are being generated through SELEX, a powerful in
vitro selection process. Our central hypothesis is that the formation of a covalent bond between an aptamer – or
a functional motif delivered by the aptamer – and its target protein will provide unprecedented residence time,
increase nuclease stability (or obviate the need for it), and facilitate aptamer selection. Furthermore, covalent
bond formation enables new applications based on the aptamer platform. The following aims will test this hy-
pothesis. Aim 1: The chemistry of covalent aptamers. To gain a comprehensive understanding of the design
principles behind covalent aptamers and to enable broad applicability, we will explore their chemistry based on
our promising preliminary results. We will explore applications in antibody drug conjugate assembly, as well as
catalytic covalent bond formation. Aim 2: Cell-based applications of covalent aptamers. We will develop several
applications that are enabled by covalent aptamers and that showcase their utility as chemical biology probes.
We are focusing on cell-surface proteins due to the rich collection of aptamers that have been reported. Aim 3:
Selection of covalent aptamers. For the de novo generation of covalent aptamers capable of selectively cross-
linking to any chosen protein target without prior sequence and/or structural information, we will develop a gen-
eralized in vitro selection process that adds distinct advantages to traditional SELEX.

Public health relevance
PROJECT NARRATIVE Aptamers are nucleic acid-based ligands for proteins, which – similar to antibodies – have found applications as research tools, diagnostic agents, as well as therapeutics. We are proposing the development of a new aptamer methodology that enables the selective crosslinking or transfer of functional handles to protein targets. This allows for new biomedical applications of nucleic acids that could previously not be developed.